MOBILIZATION OF HEMATOPOIETIC STEM CELLS WITH GCSF OR GMCSF

To ascertain the feasibility of collecting sufficient numbers of hematopoietic stem cells from the peripheral blood of normal donors treated with GCSF or GMCSF to perform hematopoietic transplants in patients who are bone marrow transplant candidates, but who lack an HLA- matched family member who can serve as a donor.